ASO and shRNA for targeting the oncogenic transcript driving fibrolamellar hepatocellular carcinoma

Fibrolamellar hepatocellular carcinoma (FLC) is a liver cancer that primarily affects adolescents and young
adults. There are no known successful therapies for this disease and surgery is the only potential path to a cure.
Once the disease has grown or metastasized to a point where surgery is no longer an option, a patient’s chance
for survival approaches zero. Unfortunately, 65% of patients are diagnosed at stage IV.
Our lab identified a recurrent genetic deletion in FLC cells, which has been found in almost all FLC tumor samples
sequenced to date, but not in normal liver tissue from the same patients. The deletion encompasses ~400kb on
chromosome 19 beginning after the first exon of DNAJB1, which codes for a member of the heat shock protein
40 (HSP40/DNAJ) family, and ends before the second exon of PRKACA, which codes for the catalytic subunit
of protein kinase A (PRKACA). This results in a functioning chimeric kinase with exon 1 of DNAJB1 and exons
two through ten of PRKACA (DNAJB1-PRKACA). We have shown that expression of this chimeric protein, but
not the native kinase, in the liver of mice results in the formation of phenotypic FLC and lethal tumors. This
strongly supports the notion that the DNAJB1-PRKACA chimera is the primary driver for this cancer. We have
shown that the structure of the catalytic site of the native and fusion kinases are almost identical and it has been
difficult to find blockers that selectively inhibit the fusion kinase.
The goal of this research proposal is to develop a therapeutic for this devastating disease utilizing antisense and
shRNA technology. This approach will allow us to specifically target the nucleotide sequence encompassing the
junction of the fusion transcript, without affecting any of the native transcripts. Our approach is to 1) screen
antisense oligonucleotides (ASOs) and shRNA with sequences that span this junction in an attempt to find the
ASO or shRNA that results in the greatest knockdown of chimeric protein; 2) assess the effects of these ASOs
and shRNA on the viability of FLC cells in vitro; 3) assess the efficacy of the ASO and shRNA to cause
knockdown of the protein in the tumor cells in FLC patient-derived xenografts growing in mice; 4) assess the
effects of the ASO and shRNA on the health of the mice, with a particular attention to liver toxicity, and 5) assess
the efficacy of the ASO and shRNA to reduce tumor burden in mice.

Public health relevance
There are many childhood cancers that have failed to respond to the latest advances in cancer therapeutics. Rather than target the protein that drives the cancer, we will eliminate the RNA that encodes for the protein that drives one of these, the usually lethal liver cancer, Fibrolamellar hepatocellular carcinoma (FLC). Our underlying hypothesis is that we can design ways of eliminating the RNA for the driver that are more specific with fewer side effects and thus produce a more powerful therapeutic than if we had targeted the protein.